Spatial and temporal control of Rho family GTPases

Many essential cellular functions require large scale organization of the cell cortex.
These include cytokinesis, asymmetric cell division, cell migration, and formation of an
epithelium. Extensive organization of the cytoskeleton and cell-cell junctions are
required during development to drive changes in the shape of cells, embryos, and
tissues. Each of these processes requires establishment and maintenance of
metastable domains that serve important cellular functions. The mechanisms by which
these domains assemble remain incompletely understood, in part due to the difﬁculty
inherent in functionally dissecting dynamic protein assemblies with current tools.
Recently developed optogenetic tools permit light-mediated control of protein activity in
live cells at high spatial and temporal resolution. This novel approach provides a
powerful means to dissect the underlying molecular mechanism underlying such
processes. We will combine the ability to alter the activity of speciﬁc molecules with high
spatial and temporal resolution with conventional cell biology, imaging, genetic, and
biochemical approaches, in order to better understand how cells divide, polarize and
shape tissues.

Public health relevance
Work in the PI's laboratory is focused on understanding the molecular mechanisms by which cells divide and dynamically change their shapes and positions during the course of normal development. Misregulation of these processes is frequently observed in cancer and developmental disorders. The project builds on a novel approach developed in the PI's lab that uses light to manipulate speciﬁc proteins in order to experimentally probe these fundamental cellular events which will enhance development of new therapies.